Improving Caries Diagnosis with Targeted Nanoparticle-Enhanced AI-Assisted Intraoral Imaging

Abstract:
This project responds to the need identified by NIDCR to develop improved methods to detect,
monitor, and predict progression of dental caries (tooth decay) to improve human health.
Worldwide, caries is the most common chronic disease affecting almost everyone. Dental disease
is major cause of economic and social loss and leads to complications including pain, tooth loss
and even death. For over a century, caries diagnosis has been performed visually and using a
dental explorer, but early caries lesions are missed, and the explorer can cause cavitation. Like
the world at large, dentistry is entering the era of Artificial Intelligence (AI), with some of the first
applications to help dentists analyze X-Rays. While radiographs identify more advanced decay,
they lack resolution to identify early disease. Newer methods for caries diagnosis show little
benefit over visual/tactile exam and incur greater cost to dentist and patient. None of these can
distinguish between active and inactive carious lesions, a critical need in modern dentistry, and a
requirement for disease monitoring. With SBIR funding (Grant 5R44DE027903-03), we have
successfully developed a clinically validated mouth rinse that uses targeted fluorescent
biopolymer nanoparticles to illuminate early active caries lesions, formulated into an FDA-
approved product, LumiCare™ (LC) Caries Detection Rinse. Our goal is to create an intraoral
camera product that can collect clinical white-light and fluorescent images of caries that are
illuminated with LC Rinse, which, in conjunction with an AI algorithm software, will provide a tool
to effectively monitor carious lesion severity and therefore track the efficacy of medical
remineralization treatments. Dental professionals would apply LC Rinse, image with the intraoral
camera, and software would determine presence of fluorescence and provide quantitative scoring
and diagnostic information (e.g., lesion depth, ICDAS severity, activity status) that can be tracked
at each appointment. Images will be available to the dental professional as a communication tool
with patients and as a record that can be used for insurance. Automated and objective early caries
detection and monitoring will enable teledentistry and public health use cases and empower
dentists and patients to use non-invasive medical treatments to improve oral health. Our
preliminary research and customer discovery activities have demonstrated the potential of this
technology. This project aims to prepare a Minimally Viable Product (MVP) optimized intraoral
camera system that can collect images which can be analyzed with computer vision software to
accurately detect fluorescence from LC-rinse illuminated caries lesions. Successful completion of
the project milestones will establish feasibility of the intraoral camera design and regulatory testing
requirements, which are critical milestones towards further clinical validation and
commercialization. Phase II will involve AI model selection and optimization, in vivo testing and
preparing for FDA 510(k) submission.

Public health relevance
Project Narrative: In this Phase I SBIR, GreenMark Biomedical Inc. will augment its recent FDA cleared caries detection diagnostic rinse, which is based on proprietary targeted nanoparticle technology, with a specialized and AI-enabled intraoral camera. The camera and targeted nanoparticle-based rinse will be used by dental professionals as part of the routine dental exam to better detect, predict progression and monitor the effect of remineralization treatment of early dental caries, empowering dentists and patients to pursue non-invasive treatments, which will result in cost savings and improved long term oral health.